Effect of Medicare Reimbursement for Care Planning on End of Life Care among Patients with Alzheimer's Disease and Related Dementias: A Quasi-Experimental Study

PROJECT SUMMARY
Alzheimer's disease and Alzheimer's Disease-related dementias (AD/ADRD) are a leading cause of
death in the U.S. More than 40% of all Medicare patients who die in a given year have AD/ADRD, and the
number of deaths from AD/ADRD are fast growing. Dying individuals with AD/ADRD use more aggressive care
at end of life, including burdensome transitions to the hospital and invasive procedures of questionable benefit,
compared to those with no cognitive impairment. Advance care planning (ACP), the process of discussing and
recording patient preferences for goals of care in the event of patient losing capacity, has been shown to
decrease aggressive treatment and increase use of hospice and palliative care, in particular among AD/ADRD
patients. Barriers to ACP exist, and no research has examined the causal effect of ACP on end-of-life (EOL)
care among AD/ADRD patients using national data. This proposal addresses these gaps by examining two
recent changes in Medicare reimbursement policy: the introduction of ACP billing codes on January 1, 2016,
and the introduction of comprehensive care planning (CCP) billing codes on January 1, 2017. The CCP targets
cognitively impaired patients and consists of several mandated components, including development, revision
or review of an Advance Care Plan. No direct evidence exists on the effect of these two reimbursement
changes on EOL care; in general or among AD/ADRD patients. This proposal will utilize Medicare claims data
merged with several supplementary data sources to examine multiple physician and patient factors associated
with ACP and CCP billing, and will innovatively apply two quasi-experimental study designs to separately
examine the causal effect of ACP and CCP billing on EOL care spending and multiple measures of EOL care
utilization commonly used as indicators for quality of EOL care, among AD/ADRD patients nationwide.
Advanced statistical learning techniques will be employed to further correct bias and improve precision of
causal estimates. The Specific Aims are: (1) To identify the physician and patient characteristics associated
with ACP and CCP billing for AD/ADRD patients; (2) To determine the effect of ACP billing on EOL care
utilization and spending among AD/ADRD patients using a Regression Discontinuity Design (RDD); (3) To
determine the effect of CCP billing on EOL care utilization and spending among AD/ADRD patients using an
Instrumental Variables (IV) approach. IMPACT: This project will provide rigorous and critical evidence to
directly inform effective policies targeted at improving EOL care for AD/ADRD patients. Further, this K01
application will establish the applicant as one the few health economists with expertise in AD/ADRD, geriatrics
and palliative care. It will prepare her to become an R01-funded independent investigator in policy evaluations
that lead to improved quality of care and quality of life for the aging population, in particular AD/ADRD patients.

Public health relevance
PROJECT NARRATIVE Deaths of older adults with Alzheimer's disease and Alzheimer's Disease-related dementias (AD/ADRD) are common and fast growing, while end-of-life care for AD/ADRD patients is often overly aggressive and costly. Advance care planning (ACP), the discussion of patient preferences and goals of care in the event of patient losing decision-making capacity, holds promise in curbing overly aggressive EOL care for AD/ADRD patients. This project aims to evaluate the effect of two recent Medicare reimbursement policy changes that promote ACP practice, providing rigorous and critical evidence for improving EOL care among AD/ADRD patients.